Genetic dissection of cortical projection neurons in social brain circuits

The autism spectrum disorders (ASDs) are characterized by impairments of social and communicative
behavior. The different, yet specific behavioral phenotypes of autism suggest impairments of specific neural
circuits of the social brain. Yet, as genetic studies of autism implicate several hundred gene variants, it
remains unclear how these genetic variants cause the behavioral phenotypes of autism. Several studies have
implicated dysregulation of gene expression in the cerebral cortex in the pathophysiology of ASD. However,
they do not address the specificity of cell types involved, how genetic changes alter brain function, or the
involvement of functionally specific brain areas. Thus, we do not know whether and how they are altering
social brain function selectively or what it is about social brain function that makes it particularly vulnerable in
autism. In order to understand autism and its causes, we need to understand how genetic alterations cause
the specific changes in the brain circuits that mediate the social and communicative behaviors altered in the
condition. The current proposal aims to establish a new approach and a new model system to answer these
questions. Using an animal model close to humans, gene expression patterns in functionally defined circuits of
the social brain will be characterized. As in human functional magnetic resonance imaging (fMRI) studies,
functionally specific regions of the social brain will be localized. This pilot proposal will focus on face-selective
brain regions, but the overall approach, once established, will easily translate to other systems. The functional
characterizations of the social brain will be complemented by the determination of the connectome of face
areas through diffusion-weighted brain imaging. With this knowledge, long-range projection neurons within this
functionally defined network will be labeled through a retrograde adeno-associated virus and cell-type specific
gene expression patterns will be measured using the Translating Ribosome Affinity Purification (TRAP). The
approach will allow for the determination of these expression patterns in glutamatergic cortical projection
neurons located in the supra- and infra-granular cortical layers. These are the exact neurons which two recent
studies have found to be highly correlated with ASD risk genes. Gene expression patterns of projection
neurons will be compared in functionally defined social brain areas to known catalogs of autism-associated
gene variations and pathways. The main expected outcome of this study will be the first determination of
autism-risk gene expression patterns of functionally identified nodes of the social brain. The rationale of this
study is that it will allow us to link autism risk genes to social brain circuits, advance the development of
etiological models of autism, and provide crucial information for the generation of transgenic non-human
primate autism models. In doing so, critical new links will be forged between the genetic analysis of ASD and
functional imaging of brain function in ASD.

Public health relevance
PROJECT NARRATIVE The autism spectrum disorders (ASD) are characterized by deficits in social behavior and likely arise from altered brain connectivity due to dysregulated gene expression in specific neural circuits. The proposed research aims to map the suite of genes actively expressed in defined neuronal cell populations that are integrated into the circuitry of the social brain of nonhuman primates, as determined by functional brain imaging, and compare these genes to the known catalogue of ASD-associated gene variations. The expected outcome of this study is the establishment of a strategy to develop models of how pathophysiological genetic alterations act on identified circuits to cause the defects in social behavior characteristic of autism that can, in future studies, be applied to other developmental and/or circuit-based disorders.